Optimizing Physical Activity Outcomes for Veterans After Total Knee Arthroplasty

More than 700,000 total knee arthroplasty surgeries are performed annually to alleviate pain and disability
associated with osteoarthritis; a chronic, degenerative condition present in 43% of Veterans using VA services.
Although total knee arthroplasty intervention improves pain and self-reported physical function, objective
physical activity remains low and nearly unchanged from pre-surgery levels up to one year after rehabilitation.
These data suggest that current conventional rehabilitation, primarily directed towards acute post-operative
impairment, does not address the key-underlying problem of persistent physical activity behaviors after total
knee arthroplasty. The negative health consequences of low physical activity are well documented. Therefore,
the primary aim of this randomized controlled trial is to assess the efficacy of physical activity behavior-change
telerehabilitation as an adjunct to contemporary rehabilitation for increasing physical activity behavior following
total knee arthroplasty. The novel, low-cost intervention incorporates evidence-based behavior-change
methods and telerehabilitation technology. Outcomes will be assessed immediately before total knee
arthroplasty, at rehabilitation midpoint, end of rehabilitation (primary end point), and 24 weeks after
rehabilitation. The primary outcome will be accelerometer-assessed average daily step count. Secondary
outcomes include: average daily time spent in standing and walking activity, self-reported physical activity (Life
Space Assessment), performance-based physical function (30-Second Chair-Stand Test, Timed Up-and-Go,
Six-Minute Walk Test), self-reported physical function (Western Ontario and McMaster Universities
Osteoarthritis Index and Veterans 12-Item Health Survey), healthcare utilization and secondary health
problems. The distinct and unique rehabilitation paradigm used in this study addresses the problem of chronic
poor physical activity following total knee arthroplasty. The proposed intervention also adds value to current VA
telerehabilitation technology by improving rehabilitation accessibility. The products of this trial will advance
rehabilitation knowledge and provide necessary evidence for the clinical implementation of physical activity
behavior-change telerehabilitation for the large population of Veterans recovering from total knee arthroplasty.

Public health relevance
While total knee arthroplasty improves the pain and disability associated with knee osteroarthritis, physical activity levels after total knee arthroplasty remain at low levels and are nearly unchanged from before surgery. Such low physical activity may account for problems seen in Veterans with total knee arthroplasty, including long-term disability, secondary health problems, and high levels of health care use. There is a clear need to advance current rehabilitation strategies to address chronic low physical activity after total knee arthroplasty. To address this need, our proposed study will assess the efficacy of using physical activity behavior-change telerehabilitation for improving physical activity outcomes. The three-month intervention is focused on changing habitual behaviors through remote video telerehabilitation sessions between Veterans and physical therapists. This innovative approach shifts the paradigm of conventional rehabilitation to specifically target poor physical activity behaviors underlying physical disability for Veterans with total knee arthroplasty.